Genetics of deep-learning-derived neuroimaging endophenotypes for Alzheimer's Disease (Parent grant)

Project Summary
Alzheimer’s disease (AD) is characterized by the progressive impairment of cognitive and memory functions
and is the most common form of dementia in the elderly. It affects 5.6 million Americans over the age of 65 and
exacts tremendous and increasing demands on patients, caregivers, and healthcare resources, making this
condition among the most significant public health problems of our time. Despite extensive studies, our
understanding of the biology and pathophysiology of AD is still limited, hindering advances in the development
of therapeutic and preventive strategies. Genetic studies of AD have successfully identified 40 novel loci but
these explain only a fraction of the overall disease risk, suggesting opportunities for additional discoveries.
Advanced neuroimaging is an essential part of current AD clinical and research investigations, which generally
focus on relatively few imaging phenotypes developed by neuro- radiologists. However, there is a growing
interest in exploiting the high-content information in large-scale, high dimensional multimodal neuroimaging
data to identify novel AD biomarkers. Deep learning (DL) methods, an emerging area of machine learning
research, uses raw images to derive optimal vector representations of imaging contents, which can be used as
informative AD endophenotypes. The overall goal of the proposed supplement is to benchmark the AI
algorithms we are developing on a standardized neuroimaging dataset. We will work on two topics: Predicting
clinical decline (prognosis) from baseline T1-weighted brain MRI, and Discovery of genetic loci in whole-
genome sequence data associated with brain MRI-derived endophenotypes. This is a collaboration with the
other two U01 awards to improve the rigor and reproducibility. We will make the software tools and results
publicly available. This will positively impact the larger research community.

Public health relevance
Narrative The overall goal of the proposed supplement is to benchmark the AI algorithms we are developing on a standardized neuroimaging dataset. We will work on two common AI tasks, including MRI-based outcome prediction and imaging genetic association discovery, that engage multiple awardees to compare, evaluate and synergize efforts across the funded awards in the ADSP AIML consortium. In collaboration with the other two U01 awards, we will make the software tools and results publicly available.